COMPUTER-BASED ANALYSIS AND IMAGE PROCESSING IN EM &LIGHT MICROSCOPY

This project is directed toward the development of computer-based mathematical and statistical analyses, pattern recognition, and image processing of data, principally X-ray micrography and electron energy loss spectra (EELS), and the electron/light microscopy of biological specimens.